Design of inhibitors targeted to the CD4 binding site on HIV - 1gp120

Project Summary/Abstract
The HIV-1 envelope glycoprotein (Env) gp120 is critical in mediating viral entry into host cells and is a prime
target for small-molecule drug and vaccine development. The recent FDA approval of the Env gp120–targeting
fostemsavir (Rukobia, ViiV Healthcare) validates this protein as a target for drug development. However, a 48-
week Phase 2b clinical trial reported several resistant mutants that reduced susceptibility to fostemsavir.
Therefore, a critical need exists for the continued development of novel drugs against this target for effective
therapies. Our group has made significant advances toward meeting this urgent need by developing a new class
of HIV-1 entry inhibitors targeting the Phe43 cavity of HIV-1 Env gp120, distinct from the fostemsavir binding
site. In addition, we discovered that some of the most active gp120 antagonists are also active against HIV-1
reverse transcriptase (RT). However, because the Phe43 cavity is very narrow and cannot accommodate any
larger scaffolds, we hypothesize that modifications to increase the RT-inhibitory activity would result in a loss of
gp120-targeted entry inhibitory activity and vice versa. Based on these considerations, we decided to focus on
optimizing the gp120-antagonistic activity in the current proposal. We gained extensive knowledge of the 3D
structural features from resolving the crystal structures of gp120–antagonist complexes. We also identified
critical 2D structural fingerprints in the inhibitors that made them strong gp120 antagonists with weak RT
inhibitory activity. We hypothesize that these novel findings from structural analyses will help to dissect the
mechanism of these inhibitors and pave the way to design and optimize lead compounds to a novel class of
entry inhibitors targeting specifically the Phe43 cavity of gp120. We aim to develop 2–3 HIV-1 entry inhibitors as
potential preclinical and clinical candidates. This well-coordinated proposal is expected to generate highly potent,
clinically relevant, orally available drugs as HIV-1 entry inhibitors and effective against resistant mutants. In
addition, these novel entry inhibitors are expected to enrich the availability of drugs that prevent virus entry by
targeting gp120 and serve as a new arsenal for combination therapies, especially in treatment-experienced
patients, contributing to the formulation of long-acting drugs.

Public health relevance
Project Narrative We discovered critical structural fingerprints in gp120 antagonists and their X-ray structures. This is a novel finding. The goal of this proposal is to develop novel, highly potent, and less toxic gp120-targeted oral anti-HIV drugs, which will serve as a new arsenal for combination therapy, especially for treatment-experienced patients.